Shared Resource: Immune Monitoring & Flow Cytometry

PROJECT SUMMARY: IMMUNE MONITORING & FLOW CYTOMETRY SHARED RESOURCE (IM&FCSR)
The Immune Monitoring and Flow Cytometry Shared Resource (IM&FCSR) provides investigators with
services and research expertise, supporting a wide range of laboratory and clinical studies in cancer
immunology and immunotherapy, transplant biology, infectious disease, and vaccine development. The
IM&FCSR produces custom-made tetramer complexes of specific peptide and major histocompatibility
complex molecules as unique reagents for assessing antigen-specific T cells and isolating these T cells for
therapy trials. Our flow cytometry service offers a wide range of instrumentation, from single-laser benchtop
analyzers to complex multi-laser cell sorters. We provide protocol-specific, flow cytometric immune monitoring
to support immunotherapy trials. We quantify cytokine proteins, as a measure of immune and other cellular
function, at technology platforms of high multiplicity, single cell, and/or ultrasensitivity. We perform specific
cellular and molecular assays of native and genetically engineered T cells for laboratory research studies and
for monitoring clinical samples. Technical assistance is available for data evaluation and interpretation, as is
assistance in optimal experimental design. The different dataset we can provide enable the characterization of
immune cell’s phenotypes and functionality, determining immune responses and tracking, and monitoring of
immune cell products during immunotherapies.

Public health relevance
Not applicable to P30 CCSG as stated in the FOA PAR-17-095.